NICHD Office of Education

The Office of Education delivers workshops, programs, and individualized opportunities to a population averaging 300 trainees, including postdoctoral, visiting, and research fellows; clinical fellows and medical students; graduate students; and postbaccalaureate fellows, as well as summer trainees. The activities include, typically: public speaking workshops, job interviewing, writing and editorial services, grantsmanship workshops, career presentations and counseling, teaching opportunities through the NICHD Becoming an Effective Scientist course for postbacs and skills workshops and a training program with the University of Maryland, and management programs. An annual retreat for fellows and graduate students is held each spring to address scientific developments and careers, which includes two keynote addresses, fellow presentations, NICHD alumni leading career round tables, and a poster presentation by each attendee. The program is developed and run by a fellow-student steering committee. Among the office's accomplishments from the past year: Dr. Yvette Pittman continues in the Office of Education as Associate Director. Our TmT (Three-minute Talks) competition, now in its third year, is held in conjunction with NIDCR and NHGRI. Dr. Alex Szatmary in the laboratory of Dr. Ralph Nossal received the third-place award. The office developed an online Annual Progress Review for fellows, launched in 2016, to track scientific and career development and progress; APRs will be provided for BSC site visits of our investigators. The database of NICHD alumni from 2008 to the present continues to be updated, leading to an expansion of our Linked In alumni group. In June 2016, the Division of Intramural Research gave its ninth Mentor of the Year awards to Julian Lui, Ph.D., in the investigator category; and Shlomo Krispin, Ph.D., fellow. Twenty FARE awards were made for the 2017 competition. A Fellows Intramural Grants Supplement (FIGS) continues to recognize and stimulate grant applications among fellows, and the Fellows Recruitment Incentive Award (FRIA) continues to support investigators who recruit postdocs from populations traditionally underrepresented in science. The NICHD Scholars program, in its sixth year, had one PhD graduate and one postbac advance to medical school; of three new postbac fellows, two are continuing for a second year, one is pursuing public health training,and two new postbacs are joining this group. The Scholars program focuses on developing talent and supporting trainees' academic and career progression. The NICHD Connection monthly newsletter published its 75th issue in August 2016 and reaches all members of the intramural division and our alumni.